Advancement of a poxvirus antiviral

Project Summary/Abstract
Poxviruses are a large group of human pathogens that include variola (the causative agent of
smallpox), mpox, and cowpox. Recent global outbreaks of increasingly virulent mpox clades have underscored
the growing need for both prophylactic vaccination and small molecule therapeutics to control the spread and
severity of poxviral disease. To date, only two antiviral drug classes (tecovirimat and cidofovir/brincidofovir)
have been FDA-approved for treating smallpox; both were developed and approved for poxviruses according
to the Animal Rule with no efficacy testing in humans. The WHO, CDC and other agencies have stated a
strong desire for at least two safe, effective small molecule therapeutics that broadly target poxviruses due to
the high perceived risk of poxviral disease both from endemic exposure as well as the potential purposeful
release of smallpox as a bioterror agent. Ongoing compassionate/emergency use of tecovirimat and
brincidofovir against mpox has raised significant concerns about their spectrum of efficacy and safety, calling
into question whether this goal has been met.
We have established a program to develop a new class of non-nucleoside small molecules called
pyridopyrimidinones (“PDPMs”) that show broad spectrum antipoxviral activity with little-to-no host cell toxicity.
Our studies to define the mechanism of PDPMs have determined that these inhibitors suppress viral mRNA
production via targeting of the poxvirus RNA polymerase (RNAP), an ideal target that is highly conserved
across all poxviruses and orthogonal to existing drug classes. Through targeted hit-to-lead medicinal chemistry
optimization we have in hand multiple advanced PDPM candidates that are potent, orally bioavailable, and
well-tolerated in mice. Now, we seek to continue our development of PDPMs as promising therapeutic
candidates for poxviral disease. So far, our medicinal chemistry program has focused predominantly on
defining PDPM structure-activity relationships (SAR) in vitro with vaccinia as a high-throughput, non-infectious
surrogate for variola and mpox. Going forward, our lead optimization will include rigorous interrogation of all
PDPMs in newly-developed in vitro assays against two emerging, clinically relevant clades of mpox (clade I
and clade II). We will continue our efforts to use genetic, biochemical and chemical approaches to define
mechanism by which PDPMs block viral replication. Lastly, we will for the first time validate the efficacy of
these molecules in animal models of poxviral disease. When these efforts are completed, they will enable
advanced (towards first-in-human) testing of a new class of poxvirus inhibitor – an inhibitor that has a
mechanism of action complementary to existing approved compounds and candidates, and a broad protection
profile, fulfilling the need for multi-compound protection from these significant human pathogens.

Public health relevance
Project Narrative Orthopoxviruses, including mpox and smallpox, are infectious agents that represent a serious threat to human health due to a rapidly increasing number of cases and well-acknowledged bioterror potential. This project seeks to continue lead optimization and development of a class of small molecules that block the ability of critical poxvirus machinery to function. We seek to continue our studies defining the compound class works, and advance promising lead candidates toward a therapeutic approach to broadly combat poxviral disease.